Functional genomics resources for the Drosophila - TR&D3

PROJECT SUMMARY – TR&D3
Development of protein technologies for use in vivo in the Drosophila system has lagged behind development
of molecular genetic technologies. In this project, we will develop protein-based technologies that complement
and extend the type of studies that can be done in this exemplary model system. We will focus on development
of proximity labeling, as facilitated by peroxidases or biotin ligases, as tools for in vivo proteomics analysis of
specific subcellular compartments and signaling. We will additionally develop a robust pipeline for isolation of
nanobodies that can be used in diverse applications, including for in vivo expression of fusion proteins that
facilitate visualization and functional blocking. Collaborators with interests in using the technologies to study
cell biology, development, transcription control, and neuronal networks provide appropriate assays for iterative
testing and improvement. Altogether, this project will help fill an important gap in the Drosophila toolbox that
can help provide a more complete picture of functions at the subcellular, cellular, organ, and whole animal
levels that would not be achievable in cell systems or using only molecular genetic tools.